Region 4, Regional Medical Library Administrative Core

Region 4 Administrative Core – Project Summary
The Spencer S. Eccles Health Sciences Library (EHSL), University of Utah, as the Regional Medical Library
(RML) for Region 4, will implement the Region 4 Administrative Core in support the mission of the Network of
the National Library of Medicine (NNLM) to provide U.S. researchers, health professionals, public health
workforce, educators, and the public with equal access to biomedical and health information resources and
data. This will include: 1) administering the regional office for the Region 4 through the utilization of effective
leadership, project management, quality improvement practices; 2) constructing a rich culture built on a
foundation of inclusive programming designed to attract and engage a diverse regional network through
effective membership management; 3) developing and maintaining a continuity of operations during large-
scale threats, disasters, and localized emergencies; and 4) providing a formative and summative evaluation of
the effectiveness, impact, and value of the RML program. Region 4 will assess and interpret the needs of
current and potential audiences and engage with these communities to offer training and funding
opportunities, all of which will expand the reach and impact of the National Library of Medicine (NLM).
Region 4 will work with the other RMLs, Offices, Centers, and the NNLM Evaluation Center to cooperatively
design, implement, and evaluate innovative approaches to serving the biomedical and health information
needs of researchers, health professionals, public health workforce, educators, and the public in communities
across the U.S., understanding that all communities require equal access to the highest level of health
information regardless of demographics.